Career Enhancement Program

The purpose of the Career Enhancement Program (CEP) of the Roswell Park Ovarian Cancer SPORE is to
support the career development of junior researchers in translational ovarian cancer research. The target
population for the program is outstanding entry-level (i.e. Assistant Professor) scientific and clinical faculty, but
in some cases may include senior postdoctoral or clinical fellows with exceptional potential for independent
research careers. A secondary goal of the CEP is to promote the diversity of ovarian cancer researchers, by
encouraging the recruitment of outstanding women, underrepresented minorities and individuals with disabilities.
The CEP will be supported both by the Roswell Park Ovarian Cancer SPORE funds and matching institutional
funds from Roswell Park and the University of Rochester Wilmot Cancer Institute. The CEP serves as a
structured mechanism for identifying outstanding candidates through an open and competitive application and
review process and matching the resulting awardees with experienced mentors. The CEP Leaders will convene
a NIH format study section and assign NIH R21-type applications to two scientific and one patient advocate
reviewers. Review results will be summarized in the Administrative Core and submitted to the Internal Advisory
Board for recommendations for funding. Successful applications will be funded at the level of $50,000 per year
for up to two years (total award $100,000). We anticipate funding four awards per year, depending on the funding
year. CEP awardees will be provided full access to the Roswell Park Ovarian Cancer SPORE Core resources,
including tissue specimens and statistical support. The CEP will directly facilitate career development through:
i) a constructive proposal review by the Roswell Park Ovarian Cancer SPORE Executive Committee and Internal
Advisory Board, which are composed of talented investigators with expertise in basic, clinical, and population-
based research, ii) research training with a mentor chosen from among a diverse faculty with broad expertise in
academic career development, and iii) access to development/enrichment programs, including ovarian cancer
disease site research group meetings, periodic SPORE meetings, seminar series, and Roswell Park Ovarian
Cancer SPORE annual retreats. In summary, the CEP provides a vital mechanism for the development of the
next generation of translational ovarian cancer researchers at Roswell Park and affiliated institutions.

Public health relevance
The ultimate long-term objective of the Career Enhancement Program (CEP) is to develop novel ways to reduce the burden of ovarian cancer, through translational, clinical, and population-based research. A prerequisite for achieving this objective is a continual influx of newly independent researchers with interest, experience, and expertise in ovarian cancer. The CEP of the Roswell Park Ovarian Cancer SPORE will support the career development of the next generation of translational ovarian cancer researchers.